Effective Ultrasound Neuromodulation in the Awake Primate Brain

Ultrasound neuromodulation promises to revolutionize treatment for neurological and mental disorders by providing pre-
cise, non-invasive treatment of the neural circuits involved in disease. Ultrasound’s strength lies in its capacity to focus
energy through the intact skull to grain of rice size regions deep in the brain. At these target regions, the ultrasound
interacts with the neural tissue resulting in modulation of the neural activity. Transcranial ultrasound neuromodula-
tion treatments are emerging in both pre-clinical and clinical studies as a promising approach to treat diseases from
depression to Alzheimer’s and epilepsy.
The effect of ultrasound on the target tissue depends on the sonication parameters—the amplitude, duration, duty cy-
cle, and pulse repetition frequency of the ultrasound pulse. Studies show that, depending on the selected parameters,
ultrasound can both excite and inhibit the target tissue. However, this flexibility is not yet utilized clinically because
the relationship between the acoustic parameters and the neural response remains elusive. This study will develop
a nonhuman primate (NHP) model capable of measuring real-time changes in neural activity after ultrasound neuro-
modulation. Thus, the study aims to deliver clinic-ready protocols capable of optimally exciting or inhibiting the target
region.
To achieve this goal we will combine two existing technologies. Remus is a remote ultrasound system capable of flexibly
delivering arbitrary ultrasound pulses to deep brain regions in an awake, behaving NHP. In.Tra is a cranial implant that
is transparent to ultrasound and thus enables functional ultrasound imaging. Combined, the two technologies enable
real-time monitoring of the awake brain’s response to ultrasound neuromodulation.
Our two aims will validate this approach by measuring the response of the awake visual system to ultrasound neuro-
modulation of the lateral geniculate nucleus (LGN). In Aim 1 we will measure the neural response of the targeted LGN
and the ipsilateral primary visual cortex. In Aim 2 we will measure changes in the correlation coefficient (a marker of
functional connectivity) between the same two regions. Both experiments will include systematic variation of the am-
plitude, duration, duty cycle, and pulse repetition frequency of the neuromodulatory sonication, including parameters
expected to excite and inhibit the targeted anatomy. Thus, validation of our platform will produce clinic-ready protocols
to suppress or excite neural activity in the targeted circuit.

Public health relevance
Ultrasound neuromodulation is a targeted and non-invasive approach to treating the precise regions in the brain that contribute to neurological disease. This project aims to develop a platform capable of measuring the interaction between ultrasound neuromodulation and the targeted brain regions. The platform will enable the development of non-invasive protocols for precise and effective treatment of neurological disorders using ultrasound.